Dissecting the mechanisms by which chromosomal instability impacts anti-Disialoganglioside responses in neuroblastoma

ABSTRACT
Although anti-Disialoganglioside (anti-GD2) therapy has significantly improved the survival rates of children
with High-Risk Neuroblastoma (HR-NBL), its clinical utility is severely limited by its life-threatening side effects
and variable response rates. Despite being standard of care for HR-NBL for over 10 years, there are currently
no existing mechanisms to predict whether a child will respond to anti-GD2 therapy. The long-term goal is to
identify predictive biomarkers for response to anti-GD2 therapy and establish a comprehensive understanding
of the therapeutic response mechanism. Our overall objective is to 1) develop a predictive statistical model
for anti-GD2 response using genomic and transcriptomic biomarkers and 2) experimentally characterize the
mechanism underlying this model. The central hypothesis is that genomic changes drive tumor cell
subpopulations with variable immune infiltration and mixed anti-GD2 responses. The rationale for this project
is that identifying predictive biomarkers for anti-GD2 response in Neuroblastoma will improve patient treatment
stratification and help identify strategies for increasing the effectiveness of anti-GD2 therapy. The central
hypothesis will be tested by pursuing 3 specific aims: 1) Define the role of genomic changes in
Neuroblastoma tumor subpopulations; 2) Characterize the role of tumor subpopulations in immune modulation
and anti-GD2 response; and 3) Generate a predictive multivariate model for anti-GD2 response in
Neuroblastoma. To assist with these aims, an institutional single cell expression dataset will be prepared for 20
Neuroblastoma patients. Diagnostic samples from anti-GD2 responders and non-responders will be
sequenced. Under the first aim, cellular-level genomic changes will be quantified in Neuroblastoma
subpopulations using publicly available and institutional single cell expression data. The second aim has 2
parts. For part one, spatial transcriptomics will be used to analyze 8 patients (4 responders; 4 non-responders)
for well-defined intratumoral tissue states known as sub-tumor microenvironments. For part two, syngeneic
mouse models will be used to assess the immunomodulatory role of the immune checkpoint related gene
CD44 in Neuroblastoma. Finally, the third aim will develop a multivariate model comprising genomic,
transcriptomic, and IHC-based features for anti-GD2 response prediction in HR-NBL. The model will be
applicable to bulk sequencing cohorts and validated in two external cohorts. The research proposed in this
application is innovative because it identifies novel genomic/transcriptomic biomarkers for anti-GD2 response
in Neuroblastoma and seeks to characterize a novel mechanism that explains response. The proposed
research is significant because it is expected to improve patient selection for anti-GD2 therapy and provide
much needed insight into mechanisms underlying anti-GD2 response in Neuroblastoma. Ultimately, such
knowledge has the potential to improve survival rates and uncover novel adjunct treatments.

Public health relevance
PROJECT NARRATIVE Although anti-Disialoganglioside (anti-GD2) therapy is standard of care for High-Risk Neuroblastoma, it is associated with a highly variable treatment response and life-threatening side effects. The proposed research is relevant to public health because it seeks to identify and characterize novel biomarkers that predict anti- GD2 response in High-Risk Neuroblastoma. The proposed research pertains to the NCI’s mission of improving cancer treatment because there are currently no predictive biomarkers for anti-GD2 response in High-Risk Neuroblastoma and little mechanistic insight into why children fail to respond to treatment.